Mechanisms of Media Literacy Education for Promoting Relationship Health in Older Adolescents

Project Abstract
Community college students are an underserved and at-risk population in terms of sexual and relationship
health. Older adolescents/young adults consume a plethora of media messages, and many media messages
about sex and relationships are inaccurate and unhealthy. Consumption of unhealthy media messages (e.g.,
those that normalize or glamorize risky sex) is related to risky sexual behaviors. Media literacy education
(MLE), which aims to enhance critical thinking about media messages, is a novel and effective approach to
relationship and sexual health promotion. A recent evaluation of a MLE program for older adolescents, Media
Aware Sexual Health for Young Adults (MASH-YA), found that the program resulted in favorable short-term
effects on community college students’ (ages 18-19) sexual and relationship beliefs and behaviors, including a
reduction in risky sexual behaviors. While evidence supports the effectiveness of MLE, there are no studies that
have attempted to isolate its effects (i.e., enhancing critical thinking about media messages) on health
outcomes, and little is understood about the mechanisms underlying the relationship between MLE and sexual
health outcomes or the trajectory of MLE effects on sexual and relationship health over time. There are also
gaps in our understanding of the challenges surrounding the effective implementation of sexual health
programming at community colleges. Thus, this project proposes conducting a three-arm randomized control
trial with older adolescents (i.e., ages 18-19) attending community college (N=1680). Community college
campuses will be randomized to either the: (1) intervention group (i.e., MASH-YA); (2) active control group
(i.e., sexual health programming from MASH-YA without MLE content); or, (3) no-treatment control group.
Students will complete online questionnaires at pretest, posttest, 6m, and 12m follow-ups. The aims of this
project are to evaluate the incremental effects of MLE on primary and secondary sexual and relationship health
outcomes, compare the mechanisms underlying MASH-YA’s effects on health outcomes to the mechanisms
underlying the effects of the active control program, and evaluate the long-term efficacy of MASH-YA on
proximal and distal outcomes compared to an active control and no-treatment control. To assess challenges
faced by community colleges in implementing evidence-based sexual health programming and gather
information to inform strategies to enhance and support program implementation, community college
personnel (N=60) will be asked to review the MASH-YA program and complete a questionnaire and
structured interview to provide feedback on the program content and implementation. MLE is an effective
approach to sexual and relationship health promotion with the potential to reduce health disparities among
community college students. The findings from this study could advance theory, inform the development of
future MLE interventions, and provide a rigorous long-term evaluation of the first evidence-based MLE
program for sexual and relationship health promotion for older adolescents.

Public health relevance
Project Narrative Media literacy education (MLE) is an effective approach to sexual and relationship health promotion for young adult community college students, but little is understood regarding the incremental impact 0f MLE above traditional sexual health programming, the mechanisms underlying MLE’s impact on health outcomes, or the long-term impact of MLE on sexual and relationship health behaviors. The purpose of this project is to conduct a three-arm randomized control trial with long-term follow-up to isolate the effects of MLE on health outcomes, examine potential mediators of MLE’s health effects, and evaluate the immediate and long-term impact of a MLE sexual and relationship health promotion program for community college students, Media Aware Sexual Health for Young Adults (MASH-YA). This project has the potential to advance theory and inform the development of future MLE health promotion programs, as well as to shift the paradigm towards community colleges implementing evidence-based sexual and relationship health programming.